Artificial Intelligence Passport for Biomedical Research: Digital Experiential Learning Community for Upskilling in Artificial Intelligence for Biomedical, Behavioral and Clinical Research

The University of Florida (UF) proposes to develop a nation-wide digital course to upskill biomedical researchers’ expertise in artificial intelligence (AI). The AI Passport for Biomedical Research (AIPassportBMR) overall objectives are to provide biomedical researchers the opportunity to augment their skills in a concise and comprehensive course based on innovative learning techniques and will be the first scalable, self-correcting AI training program that is dynamic enough to withstand constant evolution of AI technologies. AIPassportBMR will focus on technical skills while providing mentorship on how to expand biomedical research into the AI field with highly collaborative sessions that include national leaders in medical AI. Designed as a digital experiential learning community, this program will enable predoctoral trainees and early-stage investigators in biomedical, behavioral, and clinical sciences to acquire the multidisciplinary skills necessary to integrate AI into their research while creating a nationwide community of mentors and peers. Our approach aligns with the objectives outlined in the IPERT initiate to provide innovative research skills development and mentoring through the following three overarching aims: Aim 1. AIPassportBMR Program: Develop the educational and technological infrastructure for community-driven experiential biomedical AI training using a See-Practice-Share-Reflect learning approach, Aim 2. Real-World Evaluation: Implement, evaluate, and fine-tune AIPassportBMR using an implementation mapping framework and Cognitive Theory of Culture to align instructional design with learners’ scientific and educational needs, Aim 3. AI Digital Community of Practice: Build a support mosaic network of peers, mentors and coaches and the capacity for sustainable nationwide dissemination of the AI research training program. To further expand AIPassportBMR, the digital community learning platform program will be disseminated nationwide to build capacity for biomedical AI workforce development and support replication for all biomedical researchers.

Public health relevance
As artificial intelligence (AI) becomes an ever increasingly component of biomedical research the need for an AI trained workforce is essential. The University of Florida (UF) proposes to develop a nation-wide course to upskill biomedical researchers’ expertise in AI while simultaneously providing career development skills and mentoring. The AI Passport for Biomedical Research (AIPassportBMR) proposal will provide biomedical researchers the opportunity to augment their skills in a concise and comprehensive course based on innovative learning techniques while being mentored by AI experts from across the nation.